Systemic antioxidant treatment for cardiomyopathy, muscle weakness, and exercise intolerance in postmenopausal HFpEF

Abstract
Heart failure with preserved ejection fraction (HFpEF) is highly prevalent in the elderly, especially post-
menopausal women. Heart failure affects ~7-8 million patients in the United States, with HFpEF accounting for
more than 50% of all cases. The disease is a consequence of multiple comorbidities (diabetes, hypertension,
obesity, and renal dysfunction). Cardiac and limb muscles are the main organs affected in patients with HFpEF
and the main determinants of disease development and progression. Intrinsic myocyte abnormalities in older
patients with HFpEF appear to stem from mitochondrial dysfunction. However, there is no disease-specific
treatment for HFpEF. Current pharmacotherapies provide limited improvements in exercise tolerance in
patients and do not resolve the cardiac and limb muscle abnormalities. The mechanisms of HFpEF
development and progression are phenotype-specific, and a prevalent subgroup of patients with HFpEF
consists of older postmenopausal women with multiple comorbidities (e.g., hypertension, obesity, insulin
resistance/diabetes). We have developed a preclinical model of postmenopausal HFpEF that recapitulates the
exercise intolerance and essential cardiovascular, muscle, and systemic features of the disease in older
women. Data from our lab and others show diminished cardiac and limb muscle mitochondrial respiration and
contraction/relaxation dysfunction, which are accompanied by increased mitochondrial reactive oxygen species
(ROS) and oxidative stress. Increases in mitochondrial ROS impair respiration, contraction and relaxation, and
lower fatigue resistance. Therefore, excess mitochondrial ROS is a potential determinant of skeletal muscle
abnormalities and exercise intolerance in HFpEF. Our preliminary data suggest that excess mitochondrial ROS
in HFpEF is due to impaired mitochondrial glutathione transport. An antioxidant compound shown to increase
mitochondrial glutathione transport and decrease ROS in hepatocytes prevents the increase in mitochondrial
ROS induced by in vitro mimics of HFpEF in cultured muscle cells. Therefore, we propose to test the
hypothesis that systemic antioxidant treatment restores cardiac and limb muscle function and exercise
tolerance in a model of postmenopausal HFpEF. This is a novel approach to treat cardiac and limb myopathy
and exercise intolerance in postmenopausal HFpEF. The antioxidant is readily available for human
consumption and routinely used in the clinical setting. Hence, positive effects in our pre-clinical studies can be
translated immediately to clinical trials in patients.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) affects millions of people, especially older individuals and postmenopausal women. Cardiac and limb muscle abnormalities are a significant problem in HFpEF patients because it contributes to morbidity and mortality. Our goal is to test whether a compound with antioxidant properties restores exercise tolerance and cardiac and limb muscle function in a rodent model of HFpEF relevant for postmenopausal women.